DIAZEPAM AND BUSPIRONE IN LIGHT AND MODERATE SOCIAL DRINKERS

The purpose of this study is to investigate and compare the reinforcing effects of the anxiolytic drugs daizepam (Valium) and buspirone (Buspar) in moderate drinkers. Our hypotheses are: 1) that diazepam will be significantly preferred to placebo; and 2) that buspirone will not be significantly preferred to placebo.